Harnessing Observational Data through Causal Inference to Reduce Hospital Readmissions for Survivors of Pneumonia with Respiratory Failure

PROJECT SUMMARY/ABSTRACT
Candidate’s Long-Term Career Goals: By pursuing the training plan outlined in this F32 proposal, Dr. Andrew
Davis will learn key skills in clinical epidemiology, causal inference, and informatics while writing a K23 award
and ultimately becoming an independent health services researcher investigating evidenced-based
interventions to improve outcomes for survivors of pneumonia and respiratory failure.
Clinical Problem to be Addressed: Community acquired pneumonia (CAP) with hypoxemia remains a major
driver of hospitalizations, readmissions and new post-discharge morbidity. Current CAP guidelines are limited
and make no recommendations on best practices to support the safe discharge of patient’s home.
Candidate Background: Dr. Davis is a postdoctoral fellow in Pulmonary and Critical Care Medicine at Johns
Hopkins University. He received his MD from the University of Pennsylvania (2019) after completing an
Intramural Research Training Award fellowship at the NIH (2013-2015). He has coauthored 9 peer-reviewed
publications and presented 6 oral and 8 poster presentations at national conferences. His department is
strongly committed to his scientific career and has awarded him a 1-year fellowship on a T32 training grant.
Career Development Plan: In order to achieve his goals, he proposes to develop expertise in biostatistics,
clinical epidemiology, and bioinformatics through completing the research aims outlined in this proposal under
the close guidance of his mentorship team, as well as through pursuing formal coursework leading to a Master
of Health Science (MHS) degree from the Johns Hopkins Bloomberg School of Public Health.
Mentors: His primary mentor is Dr. Theodore J. Iwashyna at the Johns Hopkins School of Medicine, who has
supervised 15 K-level or equivalent career development awards of whom 10 have so far transitioned to PI of R-
level awards or equivalents. He will be co-mentored in bioinformatics by Dr. Khyzer Aziz, assistant professor of
pediatrics and Chief Medical Information Officer at the Johns Hopkins Children’ Center, and in biostatistics by
Dr. Akihiko Nishimura, assistant professor of biostatistics at the Bloomberg School of Public Health.
Aims: He will use the Johns Hopkins Precision Medicine Analytics Platform (PMAP) comprising observational
data from 2.4 million patients and 23 million healthcare encounters in both research aims. First, he will perform
a target trial emulation evaluating the effect of scheduling early primary care follow-up at discharge following
admission for hypoxemic CAP. Then he will develop the informatics infrastructure needed to investigate optimal
discharge diuretic regimens for survivors of CAP with comorbid heart failure in his future K23 award proposal.
Deliverables from Aims: His proposed aims will lead to 3-4 publications over 2 years with semiannual
presentations at national conferences. This proposal constitutes the foundation for a future K23 application to
develop evidence-based guidelines to improve outcomes for survivors of pneumonia and respiratory failure by
supporting their safe discharge home following hospital admission.

Public health relevance
PROJECT NARRATIVE Community acquired pneumonia (CAP) with hypoxemia remains one of the most significant drivers of US hospitalizations and new post-discharge morbidity, with approximately 20% of patients who survive their index admission experiencing short-term readmission. Current CAP guidelines and research focus almost exclusively on either strictly initial outpatient or inpatient care without making recommendations on discharge interventions or follow-up for patients. I propose to perform novel observational research to (1) investigate the effect of scheduling early primary care follow-up for patients with hypoxemic CAP at the time of discharge and (2) build the informatics infrastructure needed to evaluate optimal discharge diuretic regimens for the large population of patients with hypoxemic CAP and comorbid heart failure.